PHASE I STUDY OF BB 10010 IN PATIENTS WITH RELASPED/REFRACTORY BREAST CANCER

Dose-intensive chemotherapy is associated with myelosuppressive complications including neutropenia and theombocytopenia. Currently availabe hamatopoietic growth factors are able to reduce the former complication, but thrombocytopenia, and cumulative myelosuppression remain significant complications of these treatments.